Genetic approaches to probe virulence and drug resistance in Candida auris

Abstract
Fungal infections have risen in frequency and severity over the last several decades, as the
number of patients with increased susceptibility have also risen. Today, these infections are a
serious clinical problem, and new species emerge to add to these challenges. Candida auris is
one such species, having been first identified in a superficial infection in 2009. Subsequently, C.
auris has been identified in four geographic foci on three continents, and spread throughout the
world. A primary concern with C. auris is its resistance to antifungal drugs, with nearly all
isolate resistance to azoles, and many to the polyenes and echinocandins. The rapidity with
which this has happened is startling and has far outpaced research advances in this species. One
advantage is that C. auris is a haploid species and this opens the door to powerful forward
genetic approaches. To take advantage of this, we propose here to develop an insertional mutant
library with thousands of mutants, which we will validate using two highly relevant genetic
screens. To generate these mutants, we will use the bacterium Agrobacterium tumifaciens,
which transfers an integrating vector (T-DNA) to a promiscuous range of host cells, including C.
auris. We have adapted tools with which we propose to isolate ~5,000 mutants and array them
in 96 well plates, then sequence each to identify the insertion site. Our primary goal is to
develop this resource and make it available to the community. In doing so, we will validate this
library with two screens that are particularly relevant to C. auris. In the first, we have developed
an animal infection assay using the nematode model Caenorhabditis elegans that allows us to
identify avirulent mutants. In other Candida species, this assay tracks murine virulence closely,
and we have adapted it for C. auris. Our host strain, chosen for its virulence and transformation
efficiency, is also highly fluconazole resistant and we will screen for insertions that increase
susceptibility. At the conclusion of this project we expect to have (a) built a large mutant library
of random insertional mutants which we will make available to the community, (b) generated
two large datasets on virulence and drug resistance, (c) primed future mechanistic studies that
will make substantial progress in improving the outcomes of patients, and (d) determined the
applicability of the nematode model to a wide array of C. auris isolates..

Public health relevance
Candida auris is an emerging identified fungal pathogen that is very concerning because of its resistance to multiple antifungal drugs, rendering some strains untreatable. We propose here to use genetic tools to study virulence and antifungal drug resistance, to gain new insight into how this organism causes disease. In doing so, we will create a community resource that can be used for myriad purposes.